ROLE OF OXYTOCIN IN THE MODULATION OF HUMAN PHYSIOLOGIC RESPONSE TO STRESSORS

The purpose of this study is to define the metastatic suppressor role of KAI1 in prostate cancer (CaP). We hypothesize that: (Specific aim 1) KAI1 is a predictive molecular marker of metastasis and therefore a prognostic indicator in prostate cancer patients; (2) KAI1 is downregulated in prostatic intraepithelial neoplasia (PIN), the purported precursor to CaP; (3) KAI1 is involved in the transition of androgen-dependent to androgen-independent CaP; and (4) KAI1 exerts its suppressive activity at several points during the metastatic cascade.